Macrophage Regulation of the Hematopoietic Stem Cell Niche

DESCRIPTION (provided by applicant): Hematopoietic stem cell transplantation is currently the only curative treatment modality for a number of malignant hematologic diseases. Yet, despite this fact, transplant related morbidity and mortality remains high, and only a fraction of the patients that could benefit from an HSC transplant actually receive one, in large part due to the inherent risks of the procedure. Defining the regulatory mechanisms responsible for hematopoietic recovery and developing therapeutic strategies to enhance recovery and engraftment are important avenues of research with significant potential therapeutic translation, and are the focus of this application. Recent evidence indicates that a bone marrow-resident monocyte/macrophage population positively supports the hematopoietic niche and that treatment with granulocyte-colony stimulating factor (G-CSF) causes a reduction in resident macrophages, decreasing niche support and facilitating hematopoietic egress to the periphery, and we have recently demonstrated impaired hematopoietic stem cell niche function in pro- inflammatory disease such as diabetes and atherosclerosis. We aim to define how macrophages, newly appreciated effectors of tissue homeostasis, contribute to conditions in the bone marrow hematopoietic stem cell niche of consequence for human health: stem cell harvesting and engraftment under homeostatic and inflammatory conditions. We propose to define the molecular factor(s) produced by macrophages governing hematopoietic niche support and retention. Identification of these factor(s) and demonstration of in vivo activity will define novel therapeutic targets to alter the hematopoietic environment, meeting a currently unmet medical need. More broadly, defining and characterizing the activity of a unique cellular player within the hematopoietic niche, macrophages, will broaden our biologic understanding of hematopoietic regulation and its alteration during pro- inflammatory conditions, such as atherosclerosis, diabetes, and chemotherapy.

Public health relevance
PROJECT NARRATIVE Hematopoietic stem cell transplantation is currently the only curative treatment modality for a number of malignant hematologic diseases; yet, despite this fact, transplant related morbidity and mortality remains high, and only a fraction of the patients that could benefit from an HSC transplant actually receive one, in large part due to the inherent risks of the procedure. These studies will define the regulatory role of a novel cellular target, macrophages, and explore several clinically translatable strategies to improve hematopoietic stem cell harvest and transplantation using currently FDA approved compounds. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS: Hematopoietic recovery from cytotoxicity resulting from therapeutic chemotherapy, exposure to radiation, or following hematopoietic stem cell (HSC) transplantation to replace malignant hematopoiesis or correct genetic disease, requires an effective supportive microenvironment and production within that environment of cytokines/chemokines able to ameliorate damage and facilitate recovery of endogenous or transplanted HSC. Understanding the mechanisms regulating normal and recovering HSC and progenitor (HPC) function is critical for development of strategies to facilitate recovery after hematopoietic injury, more effective methods to acquire peripheral blood stem cells and transplant regimens for treatment of hematologic malignancy, and expansion of stem cell based therapies beyond malignant diseases. The number of molecules available to enhance hematopoietic stem cell transplantation is remarkably small and identification of new cellular and molecular targets within the hematopoietic niche would allow for therapeutic strategies to enhance HSC transplantation by targeting the recipient niche, meeting a currently unmet medical need. Recent evidence from three independent laboratories indicates that a bone marrow-resident monocyte/macrophage population positively supports the hematopoietic niche and that treatment with granulocyte-colony stimulating factor (G-CSF) causes a reduction in resident macrophages, decreasing niche support and facilitating hematopoietic egress to the periphery 26-28. We aim to define how these newly appreciated effectors of tissue homeostasis contribute to conditions in the bone marrow hematopoietic stem cell niche that are important for human health: stem cell harvesting and engraftment under homeostatic and inflammatory conditions. To date, the factor(s) produced by macrophages regulating HSC niche function remains undetermined. Using a candidate approach, we have discovered that Oncostatin M production from macrophages positively supports osteolineage cells, identifying a potential new axis within the hematopoietic niche regulating HSC retention and function with potential therapeutic utility. In this proposal we aim to use an innovative experimental strategy using G-CSF mobilization and macrophages to probe for the localization and characterization of the HSC niche, and define new regulatory components governing HSC retention and maintenance. Our laboratory has recently reported that mobilization and hematopoietic niche function are impaired in diabetic mice and patients 29, which was at least partly due to significantly reduced osteolineage cells within the bone marrow microenvironment. Curiously, upon further analysis, the bones of these mice contained ~2 fold more macrophages than wild type mice, seemingly contradictory to the positive supporting role of bone-marrow resident macrophages previously reported 26-28. Diabetes is a pro-inflammatory state 30-32 that can be exacerbated by cardiovascular disease 33-35. Intriguingly, results in the laboratory of our collaborator, Matthias Nahrendorf (and member of my career development advisory committee) demonstrate that in settings of atherosclerosis and myocardial infarct, both pro-inflammatory states, there is an increase in extramedullary hematopoiesis in the spleen 36-38. Given that both diabetes and atherosclerosis result in an increase in pro- inflammatory, classically activated "M1 macrophages" with a reduction in alternatively activated, pro-resolving "M2 macrophages", we hypothesize that macrophage polarity (M1 versus M2 status) is a key determinant of the hematopoietic regulatory capability of bone marrow-resident macrophages. This hypothesis would explain the seemingly disparate finding of increased bone marrow-resident macrophages in diabetic patients, yet reduced hematopoietic niche support. In addition, studies delineating the role of macrophage polarity status in hematopoietic niche regulation would define a novel and innovative cellular target for enhancement of HSC harvesting and transplantation, and potentially identify novel niche regulatory molecules for future exploration. Therefore, we propose the following specific aims: Specific Aim 1. Define how macrophages control hematopoietic stem cell retention within the niche. Specific Aim 2. Characterize the effects of inflammatory status on hematopoietic niche retention.